VIOLA: Study of Viremia on Long-acting Antiretroviral Therapy with Cabotegravir and Rilpivirine

PROJECT SUMMARY/ABSTRACT
Long-acting antiretroviral therapy (LA-ART) has the potential to improve viral suppression and accelerate
Ending the HIV Epidemic (EHE) goals in the U.S. Cabotegravir (an integrase strand transfer inhibitor, INSTI)
and rilpivirine (a non-nucleoside reverse transcriptase inhibitor, NNRTI) (CAB/RPV), an every 4 or 8 week
injection, is FDA-approved for maintenance of viral suppression among people with HIV (PWH). Based on data
from clinics and the A5359 LATITUDE trial, U.S. HIV guidelines now also recommend CAB/RPV for select
PWH with adherence challenges or persistent viremia on oral ART, ushering in an era of expanded use of LA-
ART. Although CAB/RPV was highly effective in trials, rare, but significant, cases of virologic failure occurred
among participants, resulting in emergence of 2-class (INSTI, NNRTI) resistance and limiting future ART
options with preferred regimens, such as bictegravir or dolutegravir. Rare cases of virologic failure on
CAB/RPV are being reported in routine clinical care, and early data suggest the risk of virologic failure may be
higher among PWH starting CAB/RPV with initial viremia, compared to those switching in the setting of viral
suppression on oral ART. With expanded CAB/RPV use in routine care in the U.S., investigation of virologic
failure on LA-ART is needed to inform strategies to mitigate the risk of virologic failure and INSTI/NNRTI
resistance. This application proposes a short-term, exploratory study investigating virologic failure on LA-ART,
leveraging an ongoing study enrolling across the U.S. and established laboratory methods. The proposed aims
are: 1) to assess CAB/RPV concentrations among persons with virologic failure on LA-ART and 2) to evaluate
viral resistance mutations among PWH with virologic failure on LA-ART using standard and next-generation
sequencing (NGS) methods. The proposed exploratory study, made feasible by existing infrastructure from a
larger grant, will fill key knowledge gaps on PK and resistance outcomes after virologic failure on LA-ART in
routine care across the U.S.

Public health relevance
PROJECT NARRATIVE New long-acting HIV treatments, including injections with cabotegravir and rilpivirine (CAB/RPV), will be key to ending the HIV epidemic; however, CAB/RPV occasionally fails to suppress the HIV virus, resulting in virologic failure. This study will enroll persons with HIV in the U.S. for whom CAB/RPV has resulted in virologic failure, and will use advanced laboratory methods to assess CAB and RPV medication levels and evaluate resistance of the HIV virus to CAB and RPV. This exploratory study aims to improve individual outcomes and benefit population health by informing a future research to investigate key questions on drug levels and resistance, collectively informing strategies to avert virologic failure and optimize the use of long-acting HIV treatment modalities.